Low Cost Carbon Dioxide-Based Cryoablation for Breast Cancer Treatment in Low Resource Settings

PROJECT SUMMARY/ABSTRACT
As the most commonly diagnosed cancer in women, breast cancer represents a significant
global health challenge, particularly in Low- and Middle-Income Countries (LMICs), where
survival rates are significantly lower compared to High-Income Countries. Kubanda Cryotherapy
has developed an innovative, low-cost cryotherapy device that utilizes carbon dioxide as a
cryogen, addressing the urgent need for accessible breast cancer treatment in these regions by
providing an affordable and effective point-of-care device for use in resource-limited settings.
This project aims to complete clinical readiness activities in preparation for implementation in
low-resource settings, aligning with NIH/NCI’s special interest and directly addressing the goals
of NOT-CA-21-062 in bringing minimally-invasive cryotherapy to LMICs.
Our Phase I work successfully demonstrated efficacious treatment outcomes when compared to
a commercially available argon system and the added benefits of slower cryotherapy. In the
Phase II proposal, we will first submit for FDA clearance. Testing will involve validating the
device’s substantial equivalence to our predicate through rigorous benchtop testing under GLP
conditions following cGMP conversions, as well as the standard safety, biocompatibility, and
usability studies for FDA submission.
We will then develop and complete a pilot educational training program in Nairobi, Kenya. The
training pilot program will involve the development of an LMIC-compatible echogenic phantom,
which will be used to evaluate care provider efficacy in placing and monitoring the device using
ultrasound visualization in phantom.
Lastly, we will prepare an evidence-generation framework for post-market surveillance to
support adoption by local payees. Key informant interviews will be conducted to develop a
comprehensive Health and Economic Outcomes data collection plan, which will support scaled
dissemination, reimbursement by government and insurance funds, and device adoption by a
qualified in-country scaling partner.
The ultimate goal is to offer an effective, affordable, and easily operable treatment option for
breast cancer, significantly improving the healthcare outcomes for women in LMICs while
reducing global health disparities.

Public health relevance
PROJECT NARRATIVE The proposed work aims to address the inaccessibility of breast cancer treatment for women in low-resource settings by preparing a low-cost cryotherapy device for clinical readiness to provide the first effective, accessible, and affordable point-of-care breast cancer treatment for low-and middle-income countries (LMICs). The completion of this work will culminate in an FDA 510(k) submission, the development of a comprehensive training plan for healthcare workers, and a real-world evidence generation plan to provide post-market surveillance and substantiate the value of the device for future payees. The proposed aims are pivotal in obtaining the requisite clearance, de-risking usability and implementation, and preparing the device for scale by a third-party scaling partner with global health expertise to accelerate clinical dissemination and provide the first locally available and feasible breast cancer treatment for women in LMICs worldwide.